Advancing health equity through integration of community social and HIV services

PROJECT SUMMARY/ABSTRACT
The proposed CFAR/ARC Ending the HIV Epidemic (EHE) supplement will address the “Prevent” Pillar. Social
and structural determinants of health are recognized as critical factors in vulnerability to HIV and engagement in
HIV prevention and contribute to inequities in HIV experienced by marginalized communities in the U.S.
However, HIV services are often siloed from social services, limiting the potential for people with social service
needs to also receive HIV prevention services and vice versa, resulting in missed opportunities to improve
outcomes along the HIV prevention and care continuum and general well-being of people at risk for HIV. Entre
Hermanos, Gay City, and POCAAN are 3 community-based organizations (CBOs) serving diverse populations
affected by HIV in King County, WA. They are rooted in HIV prevention and offer HIV/STI testing, PrEP services,
and case management and increasingly provide social services, ranging from substance abuse services,
immigration legal services, post-incarceration services, to health insurance navigation, with varying levels of
service integration. This proposal builds on an existing academic-community partnership and a successful EHE
planning project through which we have built consensus around objectives, drivers, and potential approaches
for enhancing service integration at each CBO. Here, we propose to evaluate practice facilitation (PF) as an
approach to enhance HIV-social service integration and thereby address social determinants of HIV and reduce
HIV-related inequities. Practice facilitation is an evidence-based approach for implementing and building capacity
for continuous quality improvement (QI) in primary care. Here, it will lead to testing and studying community-
driven and -owned practice changes for enhancing service integration, building from ideas generated by CBO
staff during the planning project. Our evaluation will be guided by the RE-AIM (Reach, Effectiveness, Adoption,
Implementation, Maintenance) framework and supplemented by constructs from Proctor’s Outcome Framework.
First, we will analyze programmatic data to evaluate the impact of PF on screening, referrals, and uptake of
social services among HIV service clients and for HIV services among social service clients as well as on
disparities in these outcomes by key demographics identified by each organization. Second, we will use process
data, staff surveys, and focus group discussions with staff to conduct a mixed methods assessment of
acceptability, feasibility, appropriateness, adoption implementation, and potential maintenance of PF. Third, we
will identify determinants of referral and uptake of social services through focus group discussions with staff.
Together, these aims will lead to strengthened, integrated HIV and social service delivery and increased capacity
to conduct QI at the three CBOs and identify models for service integration in other settings. Ultimately, the
effective integration of social services with community-based HIV services has potential to increase engagement
in HIV prevention, advance health equity, and improve client general health and well-being.

Public health relevance
PROJECT NARRATIVE The proposed administrative supplement to the University of Washington (UW) Behavioral Research Center for HIV addresses the “Prevent” Pillar of the Ending the HIV Epidemic (EHE) plan. Social and structural determinants of health are critical factors in engagement in HIV prevention and care and contribute to inequities in HIV experienced by marginalized communities in the U.S. The proposed academic-community implementation science project aims to use practice facilitation to support three community-based organizations serving diverse populations affected by HIV in King County, Washington, to integrate social and HIV services as an approach for increasing client engagement in HIV services, improving client well-being, and advancing health equity.